Mapping ankle-foot stiffness to socket comfort and pressure using a robotic emulator platform to personalize prosthesis function via human-in-the-loop optimization

The primary aim of this pilot study is to characterize the relationships between prosthetic ankle-foot stiffness,
user reported comfort, and residuum-socket interface pressure in Veterans with transtibial amputation, and use
these relationships to guide prosthesis optimization to maximize daily comfort. User comfort is of paramount
importance to leg prosthesis users and has a direct impact on satisfaction with a prostheses, use or rejection of
a prosthesis, and ultimately mobility and independence. Nearly 90% of prosthetic clinical encounters in the US
are related to the lower limb, representing the vast majority of delivered prosthetic device interventions. However,
surveys suggest that between 33% and 57% of leg prosthesis users report dissatisfaction with comfort while
wearing their prosthesis, and 39% indicated that comfort and fit were their biggest concerns with a new prosthesis
and a primary reason for changing prosthetists. Moreover, 51% and 37% of Vietnam Veterans and OIF/OEF
Service Members reported prosthesis related pain. Importantly, regular use of a prosthesis and satisfaction with
its comfort can increase the likelihood of returning to work following lower limb loss and this is a critical factor to
Veterans’ community reintegration. Self-perceived comfort is a multifactorial, dynamic, psychophysical construct,
but evidence suggests it is influenced by residuum-socket interface pressures. These interface pressures are
affected by socket design, but also by prosthesis alignment given its influence on transfer of ground reaction
forces through the socket to proximal anatomy. By the same mechanism, prosthesis stiffness should also
theoretically affect interface pressures, but this relationship has not been quantified. To this end, prosthesis
properties could be tuned to manipulate interface pressures for maximizing comfort. Therefore, the Specific Aims
of this study are: 1) Define the maps connecting prosthetic foot stiffness, residuum-socket interface pressures,
and user-perceived comfort, and 2) Assess the efficacy of human-in-the-loop optimization to tune prosthetic foot
stiffness for minimizing interface pressure independent and in addition to the clinically optimized socket.
We will address the study aims through use of novel robotic prosthesis emulator platform that includes a high-
performance mechatronic system for rapid, controlled, and high-resolution keel stiffness modulations of a
tethered prosthetic ankle-foot end effector. Both aims will involve ten participants with unilateral transtibial
amputation. For Aim 1, participants will first undergo fitting and accommodation to the emulator system and
protocol, and then walk at steady state under different prosthesis ankle-foot stiffness settings stratified by a
certain percentage from a reference value specific to their body mass that reflects a common dynamic elastic
response foot. Peak interface pressures and socket comfort will be measured at each stiffness setting to quantify
associations between stiffness, comfort, and pressures as assessed through linear mixed modelling and curve
fitting. For Aim 2, participants will also undergo fitting and accommodation to the emulator system, and then
experience a process known as human-in-the-loop optimization in which the prosthesis keel stiffness will be
automatically optimized in real-time using Bayesian control algorithms focused on minimizing an interface
pressure cost function and maximizing comfort. In addition to continuous feedback on participant experience,
peak pressures, socket comfort, and perceived effort will be compared between the optimized stiffness setting
and the reference stiffness setting of Aim 1. [For both aims, lower extremity kinematics will be measured to
assess stiffness effects on gait performance.] Results from this study will inform on the clinically important
relationships between prosthesis stiffness, interface pressures, and comfort to guide prescription guidelines for
maximizing walking comfort in Veteran prosthesis users. Our results will also set the foundation for development
of a smart prosthesis through future Merit Awards that automatically implements stiffness adjustments according
to pressure biofeedback to maintain long-term Veteran daily comfort, prosthesis use, and independence.

Public health relevance
For Veterans with leg amputation, comfort during daily use of their prosthesis is of paramount importance. Comfort can affect the satisfaction with their prosthesis, use of their prosthesis, and ultimately their mobility and independence. There is some limited evidence to suggest that comfort is directly linked to the pressures experienced by the amputated limb while in the prosthetic socket and that these pressures are affected by how forces are transferred from the ground to the amputated limb. The way in which those pressures are applied to the amputated limb can be influenced by the position of the prosthesis, but also by the flexibility of the prosthesis. The aim of this study is to help us better understand the relationships between prosthesis user comfort, pressures applied to the amputated limb, and prosthetic foot flexibility to improve Veterans’ experience using a leg prosthesis. We will use a new robotic prosthesis to study those relationships and test the possibility of using pressures applied to the amputated limb to automatically adjust prosthesis flexibility to improve comfort.